CORE--Patient Acquisition

Patient Care Core A will coordinate and facilitate the patient interface for the research in this Program Project, arranging for patients to participate in research testing, making arrangements with the relevant collaborating laboratories and obtaining blood and other samples. Patient Core A will be responsible for ensuring that all relevant IRB patient consent forms and HIPPA related materials are produced and approved by appropriate review boards. Core A will ensure that these materials conveyed to the patients, parents or guardians, and these materials signed appropriately. This Core will also be responsible for updating these IRB materials and retaining patient consent forms. The Patient Core will, establish a list of participating patients and their disgnoses, which will be related to a coding system available only to Core A, indicating age, sex and diagnosis. Patient Core A will also be responsible for giving patient's blood and other samples to Core B, in a coded manner, so that blood and other materials can be given to the participating laboratories for study, but without personal identifiers. Projects 1-> 4 will use this Core, since all projects use human blood samples. The staff of this core wilt be responsible for patient contact, and travel arrangements if needed.